Single-cell label-free identification of senescence by Raman microscopy and spatial genomics

PROJECT SUMMARY
The molecular and cellular heterogeneity of senescent cells remains poorly characterized. The knowledge gap
is mainly due to the lack of proper technology to characterize the cell states, types, and circuits in intact tissues.
Thus, we will need novel technologies to map the multidimensional parameters of senescence across diverse
tissue environments at molecular, cellular, and morphological levels and over longitudinal time frames. Single
cell multi-omics and molecular profiling assays (e.g., single-cell RNA-seq, single-cell ATAC-seq, single-cell
proteomics, methylomics, metabolomics) have opened new windows into understanding the properties,
regulation, dynamics, and function of cells at unprecedented resolution and scale. However, these assays are
inherently destructive. Cells need to be dissociated, fixed, or lysed for these molecular profiling assays. Raman
microscopy offers a unique opportunity to comprehensively report on the vibrational energy levels of molecules
in a label-free, nondestructive manner with subcellular spatial resolution. With recent advances in Raman
microscopy, single-cell and spatial multi-omics, and machine learning, we have developed “Raman2RNA” (R2R),
an experimental and computational framework to infer single-cell expression profiles in live cells through label-
free hyperspectral Raman microscopy images combined with multi-modal data integration and domain
translation. In this proposal, we aim to develop “SenNetRaman”, an innovative experimental and computational
platform to character the molecular heterogeneity of senescent cells through label-free hyperspectral Raman
microscopy, single cell and spatial genomics, and machine learning. In the UG3 phase, we aim to develop
“SenNetRaman” for characterizing single cells in lung tissues corresponding to young, naturally aged or stress-
induced senescence states from well-established mouse models. We will develop a high-throughput Raman
microscopy system for label-free characterization of the molecular heterogeneity of senescent cells and identify
Raman signals/markers predictive of gene expression and corresponding to various senescent cell states and
types. In the UH3 phase, we will demonstrate “SenNetRaman” for characterizing senescent cells across multiple
senescence model systems including human lungs, brains, and skins from an established human senescence
tissue mapping center. Overall, “SenNetRaman” is a modular and universal framework to link imaging data with
single-cell multi-omics data for building quantitative biomolecular tissue maps of human senescent cells. Our
application is innovative in the approach to study senescence by leveraging the recent advances in imaging,
single-cell genomics, and machine learning. The results of this project will help identify novel markers and reveal
new biology of senescence. “SenNetRaman” builds upon the SenNet Initiative and can be readily adapted to
existing NIH single-cell tissue mapping efforts, including the Human Tumor Atlas (HTAN), Human Biomolecular
Atlas Program (HuBMAP), and Human Cell Atlas (HCA) that will transform future biomedical and clinical research.

Public health relevance
PROJECT NARRATIVE Single cell multi-omics profiling assays (e.g., single-cell RNA-seq, ATAC-seq, proteomics) have opened new windows into understanding the properties, regulation, dynamics, and function of senescence at unprecedented resolution and scale, however, these assays are inherently destructive, precluding us from tracking the molecular profiles and dynamics of live cells in tissues, whole organisms, or humans. We aim to develop an innovative technology “SenNetRaman” by combining the recent advance in high-resolution and -speed Raman microscopy, single-cell and spatial multi-omics, and machine learning to unbiasedly map the molecular and cellular heterogeneity and spatial information of senescent cells nondestructively. Overall, we believe “SenNetRaman” is highly modular and lays a foundation for future investigations into exploring single-cell genome-wide molecular dynamics of senescent cells in tissues through imaging data, in vitro and in vivo in humans.